Exploring longitudinal and momentary effects of family functioning on obesity risk behaviors in Hispanic adolescents and family units

PROJECT SUMMARY/ABSTRACT
Hispanic adolescents in the United States are disproportionately affected by obesity compared to their non-
Hispanic White adolescent counterparts. A recommended means of addressing adolescent obesity is through
participation in family-based multicomponent behavioral interventions (targeting improvements in family
functioning as a mechanism of change). Although family-based interventions (FBIs) exist, effects on
adolescent obesity-related outcomes, especially among Hispanic adolescents, are small or insignificant.
Limited effects may be due to gaps in the existing research: 1) few FBIs have incorporated obesity-related
socioecological factors at multiple levels as tailoring variables to improve intervention effects, 2) FBIs often
overlook fathers and other household members (such as grandparents in multi-generational households) that
may also play a role on adolescents’ obesity risk behaviors, and 3) FBIs often assess family functioning
retrospectively without consideration of day-to-day family dynamics, which may also influence obesity risk
behaviors. Thus, I propose the following aims to address existing gaps: 1) conduct secondary data analysis
using five waves of data from the Adolescent Brain Cognitive Development study and the Hispanic adolescent
subsample (n=2411, Mage=9.5 at baseline) to examine the direct and moderating effects of factors at each level
of the socioecological model on the longitudinal trajectories of obesity risk behaviors/obesity status, 2) pilot an
EMA protocol with Hispanic adolescents (9-to-17 years) and household caregivers (n=20 family units) across 7
days to assess feasibility and acceptability, identify barriers and facilitators to completion of daily assessments
by family units, and make needed modifications to the EMA protocol, and 3) implement a finalized EMA
protocol over a 6-month period, using measurement burst design, and assess the effects of momentary
changes in family functioning behaviors and associations with daily physical activity, sleep, and nutrition
behaviors (n=50 family units, adolescents 9-to-17 years). The purpose of this training application is to gain
mentoring and training in the following four areas: 1) intensive longitudinal data analysis, 2) recruitment,
retention, and implementation, 3) innovative assessment design, and 4) professional development. Under the
mentorship of a team of interdisciplinary researchers, experts in either obesity prevention, longitudinal data
analysis, ecological momentary assessment, and/or minority health, Dr. Fernandez will successfully complete
the plan of research at the University of Texas Health Science Center at Houston, School of Public Health and
attain preliminary data to inform the development of a NIH-R01 proposal.

Public health relevance
PROJECT NARRATIVE Adolescent obesity in the United States continues to be an epidemic, disproportionately affecting Hispanic adolescents. This study proposal will result in research findings on 1) the role of etiological factors using a socioecological perspective on Hispanic adolescent obesity, 2) the use of ecological momentary assessment to examine momentary effects of family functioning on obesity risk behaviors, and 3) preliminary evidence used to develop an ecological momentary obesity intervention protocol. The long-term outcome of this research study includes the development of an ecological momentary intervention that has the potential to reduce obesity in Hispanic adolescents.